Human-Specific Prediction, Training, and Visualization Tools for the Tricuspid Valve from Existing Data

ABSTRACT. Roughly 1.6 million Americans suffer from significant tricuspid valve regurgitation. The standard
treatment for tricuspid valve regurgitation, surgery, is shockingly ineffective with recurrent regurgitation in up to
30% of patients within a few years. We posit that these poor outcomes are due to our very limited basic
understanding of normal valve function and the valve's underlying, fundamental disease and failure mechanisms.
Models for prediction, training, and visualization have been valuable in many other areas of surgery and could
be critical tools toward overcoming our current knowledge gaps about the tricuspid valve. However, the few
existing models of the tricuspid valve are simplified, population-averaged, not human-specific, or all of the above.
To fill this clear gap in tools, our goal is to do a secondary analysis on previous data collected on isolated,
beating, human hearts. Based on these data, we will create fully-detailed, human-specific tricuspid valve models
and curate these models as an openly available portfolio of prediction, training, and visualization tools. To this
end, we will first create detailed finite element models of the human tricuspid valve for predictive simulations.
Specifically, we will establish and validate high-fidelity finite element models of eight subjects whose leaflet and
annular geometries, leaflet and chordae mechanical/microstructural properties, and boundary conditions are all
subject-specific. We will curate these models to be compatible with the widely popular, NIH-funded, and open-
source finite element software FEBio. Because FEBio is a research code, we will make our models also
compatible with one of the most widely-used commercial finite element software, Abaqus. Second, we will create
eight responsive models of the human tricuspid valve for real-time training simulations. To this end, we will
introduce low-fidelity, but high-efficiency computational models of the tricuspid valve that use linear material
laws, dimensional reduction, simplified solution strategies, and GPU acceleration for speed-up. These models
will be of lower fidelity than our finite element models, but fast enough to be integrated into a popular and open
software suite for real-time surgical simulations: SOFA. Finally, we will also create eight augmented reality
models of the human tricuspid valve for anatomic visualization. We will make these dynamic and labelled models
openly accessible through an augmented reality web interface that hosts these models as a smart-phone
accessible resource for clinicians, patients, and engineers. Once we have successfully concluded this work, we
will have created tools for tricuspid valve predictive modeling, training, and visualization. All tools will be made
openly available through the Creative Commons Attribution-NonCommercial-ShareAlike 4.0 International
License. Together, these accessible outcomes will overcome our current tool gap for the tricuspid valve and
address a highly prevalent, unmet clinical need.

Public health relevance
PROJECT NARRATIVE. Leakage of the heart valve between the right atrium and right ventricle, the tricuspid valve, is common and, if not treated, can significantly impact the health of patients. The current gold-standard for treatment is a surgical approach called tricuspid annuloplasty, which unfortunately is not very successful and fails in the long-run in approximately one third of patients. Our proposal is relevant to public health because it uses previously collected data to build tools that will permit better medical device design, better surgical training, and better patient education and thereby addresses our currently suboptimal treatment of tricuspid valve leakage.